Duration of Immunity Elicited by Pertussis Vaccines

To advance our scientific understanding of host responses to pertussis infection and vaccination, which will guide the development of improved pertussis vaccines.